Cardiometabolic Status of Adults Living with HIV in Colon, Panama

PROJECT SUMMARY
Worldwide, metabolic syndrome (MetS) affects one-quarter of adults, increasing morbidity and mortality
due to general causes and especially due to type 2 diabetes mellitus (DM2) and cardiovascular disease (CVD).
MetS is becoming hyperendemic and, despite its important health outcomes, it remains underrecognized,
underdiagnosed, and undertreated. As adults living with HIV (ALWH) have normalized their lifespan with
advancements in antiretroviral therapy (ART), there is an epidemiologic shift towards noncommunicable
diseases, such as MetS, with prevalence rates comparable to or higher than the general population. There is
considerable paucity of clinical, laboratory, and epidemiologic data on MetS among ALWH in low- and
middle-income countries. Panama, a middle-income country, has the highest prevalence rate of HIV in Central
America and the third highest in Latin America, but does not routinely keep track of noncommunicable diseases
among ALWH. Thus, this study proposes to describe the cardiometabolic profile and 1-year trajectory among
ALWH in the Caribbean province of Colón and to determine sociodemographic, laboratory, and therapeutic
moderators of such effect. As an exploratory objective, we also will explore the feasibility and sustainability of
local, evidence-based guidelines to prevent and treat MetS among ALWH, with the long-term goal of developing
a culturally appropriate, evidence-based intervention to prevent, diagnose, treat, and follow-up MetS among
ALWH in Panama and adapt it for the rest of Latin America. Such intervention must be informed with the baseline
MetS epidemiology and the risk and protective factors among ALWH, while building research and clinical
capacity and buy-in from key local stakeholders. Thus, in this study, we aim to:
1. Estimate the overall prevalence and 12-month trajectory of MetS and its five diagnostic criteria (i.e.,
abdominal obesity, hypertriglyceridemia, reduced HDL cholesterol, hypertension, and hyperglycemia) among
ALWH in Colón, Panama.
2. Describe and estimate the overall effect of therapeutic, laboratory, and socio-demographic variables on the
prevalence and trajectory of MetS its five diagnostic criteria in ALWH in Colón, Panama.
3. Adapt clinical and preventative MetS guidelines to implement a pilot, clinical workflow for the assessment
and treatment of MetS in ALWH in Colón, Panama, and evaluate its feasibility, acceptability, sustainability
within the ART Clinic’s local capacity.

Public health relevance
PROJECT NARRATIVE Through well-established epidemiologic methods, we will determine the prevalence and trajectory of metabolic syndrome among adults living with HIV in Colon city, Panama. Understanding the epidemiology of metabolic syndrome in this population is a necessary first step to inform our long-term goal to develop and implement evidence-informed interventions to prevent, screen, follow-up, and treat metabolic syndrome and its untoward health outcomes (such as cardiovascular disease and diabetes) among adults living with HIV in Latin America. By understanding the local epidemiology, the factors that have an effect on metabolic syndrome, and generating local capacity through clinical guidelines, we expect to advance the field of cardiometabolic health in adults living with HIV.